USC/UCLA Center on Biodemography and Population Health: Enhanced Contextual Data Resource (CDR) for Understanding the AD/ADRD Exposome

PROJECT SUMMARY
This is an application for a supplement to the USC/UCLA Center on Biodemography and Population Health
(CBPH) (P30AG017265) to create an Enhanced Contextual Data Resource (CDR) for Understanding the
AD/ADRD Exposome. The CBPH provides a synergistic research environment that supports activities to
enhance understanding of the social and biological processes that contribute to population health and health
disparities at older ages. The physical, chemical, and social environmental exposures that constitute the
exposome undoubtedly play an important role in shaping health over the life course, but the impact of the
exposome on AD/ADRD outcomes is not fully understood. One of the major challenges in research on the
AD/ADRD exposome is the lack of readily available and linkable data on environmental exposures. The
difficulties inherent to the acquisition, management, and analysis of contextual data represent a formidable
barrier for both new and experienced users. These barriers include the high up-front costs of obtaining and
processing data so it can be linked to survey respondents over time, intensive time commitments required to
create summary and longitudinal measures of environmental context, and lack of training in how to use such
data in models of health and aging. This supplement overcomes these barriers by leveraging the Center’s
existing expertise in building data resources as well as its infrastructure for data dissemination and user
support to create a comprehensive AD/ADRD exposome focused CDR. Through this administrative
supplement we will greatly enhance the research infrastructure around exposome data with improved temporal
and spatial coverage of data sets and the creation of additional user resources to facilitate use of the data by
both established researchers and those who are new to the AD/ADRD field and/or geographic and
environmental research. The proposed supplemental activities will also take advantage of newly available data
enclaves to provide even more rapid dissemination of this data resource to the community of researchers in
aging, and specifically AD/ADRD.

Public health relevance
Project Narrative This administrative supplement will support a major expansion of a Contextual Data Resource with an emphasis on data relevant to the AD/ADRD exposome and rapid dissemination of data to the user community. The overall objective of this project is to create a collection of user-friendly datasets that enables researchers to study the impact of the social, economic, physical, chemical, built, and resource environment on levels, trends, and disparities in ADRD, and the cognitive and functional decline that precede it.